PHASE III MULTICENTER TRIAL OF SAFETY AND EFFICACY OF 1592U89 IN HIV DEMENTIA

The study evaluates the safety and efficacy of 1592U89 (ABACAVIR) in patients with HIV dimentia. The study enrolled approximate 90 patients.